Nuclear mechanobiology in confined migration

Project Summary
The nucleus is the defining feature of eukaryotic cells; it is also the largest and stiffest cell organelle. Increasing
evidence suggest that these physical properties of the nucleus can affect diverse cellular functions, and that
mechanical forces acting on the nucleus conversely modulate nuclear structure and function, including chromatin
organization, gene expression, and genomic integrity. This ‘nuclear mechanobiology’ is particularly relevant in
the context of cell migration in 3D in vivo environments, where cells frequently move through tight interstitial
spaces that require substantial deformation of the cell nucleus. Examples include cell migration during
development, wound healing, inflammation, and cancer metastasis. Our laboratory previously demonstrated that
the required deformation of the nucleus limits the ability of cells to migrate through tight spaces, with highly
migratory cells often having more deformable nuclei, and that nuclear deformation associated with confined
migration can lead to transient nuclear envelope rupture, DNA damage, and changes in chromatin organization.
These findings point to an exciting new concept in which the deformation of the nucleus as cells move through
tight spaces could activate or suppress transcriptional programs that further enhance migration and modulate
other functions, or that could lead to the selection of cells particularly adept at such confined migration.
Nonetheless, many questions remain. Over the next five years, we will focus on three complementary and
synergistic overarching research areas: (1) investigate how cells generate, apply, and coordinate the large
cytoskeletal forces required to move and deform the nucleus through confined spaces; (2) identify the
mechanism(s) responsible for confined migration induced changes in chromatin organization, and (3) determine
the functional consequences of confined migration on cellular fate and functions, along with the underlying
mechanisms. Towards this goal, we have developed several novel experimental platforms that enable extended
live-cell imaging of cells migrating through precisely-defined microenvironments while visualizing nuclear
deformation, nuclear envelope rupture, DNA damage, and chromatin modifications, and that allow collection of
cells after confined migration for subsequent analysis. We will pair these platforms with molecular biology
approaches and assays for genome-wide analysis of changes in 3D chromatin organization and gene expression
in a range of different cell types, reflecting physiological and pathological scenarios. Our ultimate goal is to
uncover general principles in nuclear mechanobiology that will lead to an improved understanding of the impact
of migration through tight spaces on cellular function and fate, including the activation or suppression of specific
transcriptional programs that may further enhance cell migration or modulate other cellular functions. Insights
gained from these studies may help guide therapeutic approach for a variety of clinical conditions, from wound
healing and immune-responses to therapies targeting metastatic tumor cells.

Public health relevance
Project Narrative Cell migration is critical for many physiological processes, such as wound healing and immune cell response, and also plays an important role in cancer metastasis, i.e. the spreading of tumor cells to distant sites in the body. As cells migrate through the body, they must frequently pass through tight spaces within tissues, placing substantial physical stress on the nucleus, which can result in DNA damage and changes in chromatin organization. The studies proposed in this application will (1) determine how cells move their large and relatively rigid nucleus through tight spaces, (2) elucidate the molecular mechanisms responsible for the changes in chromatin organization, and (3) identify the consequences of such confined migration on cellular fate and function, with the goal to obtain a better understanding of how migration through confined environments can modulate the function of normal cells but may also promote cancer progression and resistance to therapies.